A Platform for Modeling the Global Impact of Climate Change on Infectious Disease

DESCRIPTION (provided by applicant): The inevitability of global climate change has led to speculation regarding its effects on the incidence and distribution of infectious disease risk. This important topic has received well-deserved attention in the form of hypothesis-driven research aimed at untangling the relationships between climate and infectious disease, usually focusing on one disease in a specific population or geographic region. However, no study has systematically examined the impact of climate change on the global burden of infectious diseases. Though a comprehensive approach is ambitious, informatics tools, statistical methods and computing capacity now exist to begin to address this challenge quickly and efficiently. We propose to model global relationships between climate and disease risk and to use these models to project future effects of climate change on infectious disease risk. By coupling new technologies for automated, global disease outbreak detection with existing climate data we will comprehensively assess climate-disease relationships on a global scale. Leveraging our previous experience in climate-based disease modeling and our development of HealthMap.org, a leading global infectious disease surveillance system, we will explore an informatics approach to investigating the predictive relationships between climate and a number of infectious diseases. The goals of our proposed research are to broadly characterize the global effects of climate on infectious disease risk and burden and to evaluate the resulting models under future climate change scenarios to project changes in global disease risk due to climate change. First, we plan to validate the use of event-based infectious disease surveillance data sources for tracking spatiotemporal trends in global infectious disease risk and burden. Building on our previous efforts in identifying informal sources for outbreak surveillance, we will assess the reliability of these sources for analyses of large-scale, long-term epidemiological patterns. Second, using this validated data, we will identify the diseases most sensitive to climate and build disease-specific predictive spatiotemporal models of relationships between climate and infectious disease risk and burden. Finally, we will leverage existing climate change forecasts to evaluate our models under various climate change scenarios. Coupled with global population growth projections, these models can be used to predict changes in populations at risk as a consequence of climate change. Guided by our advisory group including partners at the WHO, Fogarty International, Red Cross/Red Crescent Climate Center, and NASA, we plan to frame our results in a policy- relevant manner that will inform ongoing international surveillance and impact assessment efforts.

Public health relevance
PROJECT NARRATIVE While the inevitability of global climate change has led to speculation regarding its effects on the incidence and distribution of infectious disease risk, no study has systematically examined the impact of climate change on the global burden of infectious diseases. We propose to couple new disease surveillance technologies and advanced statistical methodologies with global climate data in order to broadly characterize and analyze the global effects of climate on infectious disease risk and burden. Our goal is to project the likely changes in global disease risk due to climate change and to inform ongoing surveillance and impact assessments efforts of international organizations, such as the World Health Organization and the Red Cross. __SpecificAimsTextDelimiter__ RESEARCH PLAN A. SPECIFIC AIMS The inevitability of global climate change has led to speculation regarding its effects on the incidence and distribution of infectious disease risk. This important topic has received well-deserved attention in the form of hypothesis-driven research aimed at untangling the relationships between climate and infectious disease. These studies have usually focused on one disease in a specific population or geographic region. While these studies have been a key to illuminating the biological basis for interactions between climate and disease, there have been few attempts at developing global models that address the likely effects of climate change on health and existing models have thus far omitted many important infectious diseases. In fact, no study has systematically examined the impact of climate change on the global burden of infectious diseases. Though a large-scale approach is ambitious, informatics tools, statistical methods, and computing capacity now exist to address this problem quickly and efficiently. We aim to couple new technologies for automated, global disease outbreak detection with global climate data in order to comprehensively assess climate-disease relationships on a global scale. We will base our framework on the wealth of infectious disease data found through automated Internet-based data gathering approaches. Leveraging both our previous experience in climate-based disease modeling and our development of HealthMap.org, a leading global infectious disease surveillance system, we will examine the feasibility of a data mining/informatics approach to simultaneously examine the predictive relationships between a number of climate variables and infectious disease. The goals of our proposed research are to broadly characterize and analyze the global effects of climate on infectious disease risk and burden, and to evaluate the resulting models under future climate change scenarios in order to project likely changes in global disease risk. Guided by our advisory group including partners at the World Health Organization, NIH Fogarty International Center, Red Cross/Red Crescent Climate Center, and NASA, we plan to achieve the following three aims: Aim 1: Validate the use of event-based infectious disease surveillance data sources for tracking spatiotemporal trends in global infectious disease risk and burden. Building on our previous efforts in identifying informal sources for outbreak surveillance, we will assess the reliability and validity of those sources for analyses of large-scale epidemiological patterns. We will use data from the WHO Global Atlas to assess the validity of our outbreak surveillance system, Healthmap, for providing an accurate picture of disease activity. We will use the WHO's 'standard' disease reporting data to systematically evaluate the spatial and temporal correspondence between our event-based surveillance systems and traditional surveillance methods. This will allow us to understand the biases inherent in our surveillance data system and correct for them in the model- building steps in Aim 2. Aim 2: Build spatiotemporal models for global predictions of the effects of climate on selected infectious diseases. We have designed a spatiotemporal modeling framework that can be tailored to a variety of different infectious disease systems. Because different disease systems will respond in different ways to climate, we aim to build climate-based models that are tailored to the epidemiological patterns of interest for each disease. Using the global event-based data validated in Aim 1, as a first step towards a complete global climate-disease model, we will identify the diseases most sensitive to climate and build disease-specific predictive spatiotemporal models of the effects of climate on infectious disease risk and burden. Aim 3: Evaluate our models under future climate change scenarios to forecast the effects of global climate change on the spatiotemporal patterns identified in Aim 2. Using our models developed in Aim 2 and data describing future climate change scenarios, we will evaluate the predicted change in the spatiotemporal dynamics of the infectious diseases under various climate change scenarios. Coupled with global population growth projections, these predictions can be used to estimate differences in populations at risk for infectious diseases as a consequence of climate change. Outlook: The universe of relationships to be discovered between climate and infectious disease epidemiology is complex and varied, and well beyond the scope of this proposal. To that end, we will make publicly available through a web-based interface the datasets and models that are a result of this study by converting our validated, historical dataset of event-based surveillance data into a publicly searchable database of disease outbreak alerts with a detailed output including temporal and spatial coordinates.